VASOPRESSIN, CIRCADIAN RHYTHMS, AND REPRODUCTIVE AGING

The primary goal of the proposed research is to better understand mechanisms of brain aging. These experiments will examine the neural control of reproduction in the aging female rat as a model system. This model provides unique advantages for studying brain function during aging because the changes in the reproductive system occur early in the life-span, and occur in the absence of confounding age- related pathologies. This research will determine specifically if age-related changes in reproductive cyclicity result from a desynchronization of neural and endocrine rhythms which are driven by the circadian timing system. Many age-related pathologies including sleep-wake disturbances and depression have been linked to this neural system. These experiments will lead to new and significant information regarding the circadian timing system itself, and will help provide a foundation for possible therapeutic intervention of disorders involving the ciradian timing system.